Clinical Phenotyping and Molecular Integration Core

PROJECT SUMMARY Clinical Phenotyping and Molecular Integration Core (Core B)
Our innovative application seeks to understand the how heterogeneity neutrophil populations in the lung impact
pneumonia and asthma development and outcomes by intersecting large scale clinical data collected during the
course of care for people with severe pneumonia with high-dimensional genomic, transcriptomic and functional
data. The overall goal of the Clinical Phenotyping and Molecular Integration (CPMI) Core is to curate patient
samples at participating sites and develop and implement strategies that support phenotypic and mechanistic
characterization of patient participants by integrating information from electronic health record (EHR) data, multi-
omics, spatial-transcriptomics and neutrophil functional studies. This core, which will sit at the heart of the Neu-
Lung project, will have sites at both Northwestern University (NU) and National Jewish (NJH), which will be
responsible for development of datasets for the pneumonia and asthma samples, respectively. While the NU
core will focus on a set of previously collected samples and associated clinical data, the team at NJ will collect
samples from asthma patients during the course of Neu-Lung. Both sites in the CPMI will then apply a similar
analysis pipeline 1) clean and curate clinical samples and data, 2) integrate clinical and molecular profiling data
for each patient and 3) apply effective machine learning strategies to develop models of neutrophil behavior in
the context of their lung disease focus area. The design of this core is based on the premise that data captured
during the course of clinical care that provides a thorough description of the patient and their environment are
essential for understanding the results of functional and multi-omic analyses and identifying clinically and
mechanistically relevant subpopulations of patients. Achieving the goals of this project will require tight
integration of clinical and molecular profiling data and the development of novel machine learning strategies that
can translate a complex set of multi-dimensional datasets into interpretable and actionable information to support
clinical care and mechanistic studies. In particular, we will leverage tailor- made algorithms for an integrative
analysis of multiple omics data sets with clinical that enable modeling of the underlying gene regulatory networks.
Datasets and metadata will be archived in the appropriate NIAID and/or NCBI archives and computational tools
will be made available for broader use through a GitHub repository. In addition, we will develop web-based tools
that will allow Neu-Lung researchers to interact with the study data repository and both browse and analyze the
collected data. Aim 1: Curate clinical samples and metadata from patients with severe pneumonia and lung
transplant recipients. Aim 2: Collect and curate clinical samples from patients with asthma. Aim 3: Implement a
data integration-analysis-modeling pipeline and web-based data analysis portal and disseminate data and code
developed during the Neu-Lung program.

Public health relevance
NARRATIVE A project narrative is not required for this component per instructions stated on the Funding Opportunity Announcement RFA-AI-22-069, “Project Narrative: Do not complete.”